Reproductive intentions and contraceptive behaviours

1 Project Summary
2 The proposed research aims to identify the drivers of women’s sexual and reproductive empowerment, including
3 male influences and subsequently demonstrate the predictive effect women’s SRH empowerment as a
4 mechanism to reduce unintended pregnancies by increasing their ability to better align their reproductive
5 intentions and behaviors. The project takes place in Burkina Faso, a high fertility and highly patriarchal country
6 in West Africa. It leverages existing data from the Performance Monitoring for Action (PMA) project, which
7 collects nationally representative longitudinal data on a range of SRH measures, including a validated SRH
8 empowerment scale. PMA currently includes 3500 partnered women of reproductive age who responded to four
9 annual surveys between 2019 and 2024. The project will expand the PMA female panel by adding a male
10 component, developed using a sequential mixed model design, including 1) a qualitative study among 120 adult
11 men in 4 communities in Burkina Faso, 2) cognitive interviewing and pilot testing of a novel SRH male module
12 derived from the qualitative study and 3) two new rounds of PMA panel data among 4500 couples, to enrich the
13 understanding of women’s SRH empowerment through a gender lens. Our specific aims are three-fold:
14 Aim 1. Evaluate short- and long-term changes in SRH empowerment and identify predictors of these
15 changes. we will use latent trajectory model and linear growth modeling to identify sociodemographic and life
16 events that predict yearly and long-term changes in SRH empowerment scores based on 4 rounds of existing
17 PMA female data.
18 Aim 2. Understand and evaluate men’s influence on women’s SRH empowerment. We will conduct a
19 qualitative study and use thematic analysis to understand men’s perspectives on childbearing and contraceptive
20 decisions. Findings will inform the development of a new male SRH module, that will be pretested and added to
21 the existing PMA female panel. We will use linear regression models to evaluate men’s influence on the
22 development and exercise of women’s SRH empowerment across the reproductive life span using couple linked
23 data.
24 Aim 3. Evaluate the effect of SRH empowerment on reproductive intentions and behaviors, accounting
25 for men’s influences. Adding an additional round of PMA couple data, we will employ generalized estimating
26 equation models to assess the predictive effect of women’s SRH empowerment in reducing the intentional gap
27 between fertility and contraceptive intentions and the behavioral gap between contraceptive intentions and
28 behaviors. We will also examine if male and couple factors change these associations.

Public health relevance
Project Narrative This project offers conceptual and methodological advances exploring the pathways linking women’s sexual and reproductive empowerment to reproductive intentions and behaviors in West Africa, while accounting for male influences. Specifically, the project tests whether women’s empowerment bridges the intention gap between fertility and contraceptive intentions and accelerates the translation of contraceptive intentions into use, and whether men influence these associations. Project results can directly inform interventions that increasingly aim to empower women and engage men to improve women’s sexual and reproductive health.